GENOMICS CORE

PROJECT SUMMARY/ABSTRACT – GENOMICS CORE
The goal of the Genomics Core is to provide IDDRC-supported projects with access to state-of-the-art
technology and expertise relevant to understanding genetic factors associated with intellectual and
developmental disabilities (IDD). The Genomics Core accomplishes its mission through four specific aims. In
Aim 1, the Core provides consultation services for genomics research. These services include facilitating
protocol development for IRB-approved human subject research, offering guidance to researchers and
clinicians about study design and appropriate utilization of next-generation sequencing technologies and
specialized genomics applications, and offering assistance in grant applications that involve genomics projects.
The second Aim is to provide genomics services in the general areas of next-generation sequencing,
genotyping, cytogenetics and chromosomal microarray analysis. This includes specialized genomic services
ranging from whole exome and whole genome sequencing, RNA-seq, and ChIP-seq to single molecule
sequencing. The Core offers a full-service CAP certified biorepository. For Aim 3 the Genomics Core assists
with data analysis, offering guidance on the use of compute resources to store and analyze data including the
interpretation of genomics data. Aim 4 is to provide educational activities and dissemination opportunities,
including a variety of workshops and classes. These Specific Aims are integrated with each other and with
other Cores of the IDDRC. The Genomics Core places a heavy emphasis on the etiology, natural history and
prognosis of a variety of conditions associated with developmental delay and specific features of
developmental disabilities. This emphasis helps IDDRC researchers to elucidate the phenotypic variations
which are associated with genetic mutations (e.g., chromosomal anomalies, genomic copy number changes,
single nucleotide variation and short insertions and deletions [indels]).